Optimizing Safety Toolkits for Elopement: Secondary Data-Analysis of a Treatment Study

Project Summary/Abstract
Elopement is an incredibly dangerous and prevalent behavior among individuals with autism spectrum disorder
(ASD). While behavioral interventions are often effective at reducing elopement attempts, access to these
services are limited, especially in areas with primarily rural or minority populations. An important resource for
families, especially those with limited access to behavioral interventions, are safety toolkits. These are
resources available online for parents and clinicians that include several strategies that may prevent some
instances of elopement (e.g., locks on doors), improve the speed of finding a child who has eloped (e.g.,
identifying search teams), and reduce the potential harm following an elopement episode (e.g., teaching traffic
safety). Safety toolkits have several advantages, primarily in their availability as a free resource that can be
immediately provided to parents. However, results from a randomized clinical trial that incorporated safety
toolkits for elopement suggest that parents of autistic children who elope may not consistently implement
recommendations from these toolkits without clinician follow-up and support. Given this, it is important to
modify and optimize these toolkits to improve ease of use. This project aims to use secondary data from a
randomized clinical trial of a behavioral treatment of elopement to guide the development of a modified toolkit.
Specifically, caregivers in the parent study completed detailed parent target problem narratives of their child’s
elopement. We aim to use these narratives, along with additional participant information, to develop
subcategories of elopement following analyses akin to past studies that have subtyped other topographies of
challenging behavior (e.g., aggression). All caregivers in the parent study were also provided with safety
toolkits, but groups differed in the amount of follow-up support provided by clinicians to complete the toolkit
strategies. Thus, we aim to conduct additional analyses to determine which items from the toolkits were most
likely to be implemented by parents on their own versus which were only implemented with the assistance of a
clinician. These secondary analyses will be summarized and provided to a group of expert clinicians,
researchers, and stakeholders (e.g., caregivers of autistic youth, autistic individuals, autism agency
representatives) who will use the information to guide development of a modified toolkit that tailors
recommendations to the type of elopement and service-delivery model. The end deliverable will include a
modified toolkit that provides more tailored recommendations with the aim of improving usability.

Public health relevance
Project Narrative Parent resources for elopement, including safety toolkits aimed at reducing the negative impact of elopement, are an important resource for parents of children who engage in this dangerous behavior. Unfortunately, there is little research on these toolkits and data from a clinical trial targeting elopement suggests parents are often not able to follow through with toolkit recommendations without support from a clinician. Thus, the goals of this study are to conduct secondary analysis of data from a clinical trial targeting elopement to identify subtypes of elopement and identify the types of safety recommendations parents are most and least likely to implement on their own, with the end deliverable of incorporating stakeholder feedback in the development of a modified toolkit that is optimized for ease of implementation based on the service delivery model and specific presentation of the child’s elopement.